Molecular Biology

PROJECT SUMMARY
The Molecular Biology (MB) Core has been created to meet the need for advanced molecular biology support
by PJIs. In particular, access to and experience in utilizing advanced molecular biology that are limited for most
PJIs and established NIH-funded investigators. Specifically, MB Core will leverage and expand the resources
and expertise of the Genelab Core facility which is comprised of three existing Core Facilities operated by the
Division of Biotechnology and Molecular Medicine (BioMMED) at the LSU School of Veterinary Medicine
(SVM): Gene expression and sequencing Laboratory (GeneLab), Protein characterization and purification
laboratory (PCPL), which is also responsible for generation of monospecific antibodies to proteins of interest,
and the Molecular Immunopathology laboratory (MIPL) that provides expertise and access to bioimaging and
advanced immunofluorescence and electron microscopy. These three laboratories are currently co-supported
by the NIGMS-funded CEIDR-COBRE (Phase III) as well as the Louisiana Biomedical Research Network
(LBRN/INBRE). The goal of the MB Core Facility of the Lung COBRE is to provide high quality instrumentation,
sample preparation and training in a broad spectrum of fundamental and advanced molecular biology
techniques to all COBRE PJIs and other NIH-funded investigators to achieve their research objectives. The MB
Core has established 2 specific aims. Aim 1 is to provide the COBRE and other NIH-funded investigators with
resources and expertise in molecular and cell biology, including instrumentation, technical support,
consultation, and training. Aim 2 is to organize, coordinate, and facilitate interactions among COBRE
investigators, mentors, and students, promote the development and use of new technologies and assays, and
train PJI faculty, staff, and students in advanced molecular biology technologies.

Public health relevance
NARRATIVE The establishment of the Molecular Biology (MB) Core is important to meet the current and future needs of LSU and other institutions. Therefore, the establishment of the MB Core is intended to be a permanent core at LSU that we will establish, expand, and transit to an independent core during the Phase I-III COBRE in order to provide facilities for genotyping of mice and pulmonary gene expression analysis following infectious and noninfectious assault.